Administrative Core

PROJECT SUMMARY/ABSTRACT
Many cancer patients and survivors suffer from adverse effects due to treatment that can arise both during
and after the completion of cancer therapy. The COBRE Center for Studies of Host Response to Cancer Therapy
supports investigators from various disciplines who 1) research the mechanisms by which cancer therapy causes
adverse effects, 2) identify new methods for detecting side effects sooner, and 3) develop novel strategies to
prevent or reduce side effects. The purpose of the Administrative Core (Core A) is to build a self-sustaining
research Center by maximizing opportunities for investigators to succeed and by promoting interactions and
synergy within the Center and with other research units in the institution. Core A will provide an efficient,
integrated administrative infrastructure for the COBRE Center (Aim 1), accelerate scientific growth through
faculty development and scientific advising (Aim 2), and expand and advance the Center toward self-
sustainability (Aim 3). A primary function of the core is to provide administrative support for project leaders and
to manage financial affairs for the Center as a whole. Core A ensures there is effective communication within
and among the projects and cores. Additionally, the core provides the infrastructure for scientific advising and
faculty development, which will encourage scientific progress for project leaders and will help integrate their
efforts with those of other scientists on campus. With assistance of the External Advisory Committee, new project
leaders will be recruited and selected to replace those who graduate from COBRE advisee status. The Center
also will perform a systematic, objective evaluation of activities, project leaders and their research, scientific
advising and faculty development programs, and core functions. This strategy will ensure the long-term success
of the Center as an independent but well-integrated investigative unit on campus with a vibrant and synergistic
research environment that comprehensively addresses the short-term and long-term side effects of cancer
therapy.